Transcranial stimulation combined with auditory training

Project Summary/Abstract
The goal of this project is to investigate the potential of transcranial stimulation to enhance intelligibility in
speech mixtures in older adults struggling in these environments. Many older adults with and without
sensorineural hearing loss (SNHL) struggle with speech-on-speech (SOS) understanding, likely as a result of a
mixture of peripheral and central deficits in the auditory system. Whereas the peripheral deficits represent a
hard limit on performance, central deficits may be improved with experience and training. There are many
auditory training programs available that aim to optimize a listener’s performance in SOS environments, but the
benefits of these programs can be small and variable across listeners. Recent evidence shows that
transcranial alternating current stimulation (tACS) – a safe and non-invasive low level of current applied to the
scalp – can lead to improved speech-in-noise understanding in young normal hearing (NH) listeners and older
adults with SNHL during the course of stimulation. Furthermore, transcranial stimulation studies in other
domains show that it can enhance benefits from cognitive training in older adults, with effects persisting for
months. However, it is not known if tACS can enhance intelligibility or reduce listening effort for SOS in older
adult listeners specifically struggling with SOS understanding, or if tACS can enhance benefits from auditory
training during or beyond the course of stimulation. In this exploratory R21 proposal, older adults reporting and
demonstrating struggles in speech mixtures will be randomly assigned to Active tACS or Sham tACS groups.
All participants will be tested in the first visit on a baseline SOS recognition task, and again on a SOS task with
Active or Sham tACS. Participants will then complete two weeks of computer-based auditory training at home
(the Listening and Communication Enhancement, “LACE”, program; Sweetow and Sabes, 2006). Participants
will visit the lab twice during the LACE training period to undergo Active tACS or Sham tACS during the SOS
task. Listening effort will be assessed via pupillometry measured concurrently with the SOS task and via a
questionnaire through the LACE program. Performance on the SOS task will be re-assessed at 4 weeks
following enrollment in the study to assess retention of benefits. By comparing the in-laboratory change in SOS
performance and listening effort in the Active and Sham groups relative to baseline in the first visit, this project
aims to determine if tACS can improve speech intelligibility and/or reduce listening effort in listeners who
struggle with SOS (Aim 1). By comparing LACE performance and SOS performance and listening effort at all
subsequent visits, this project aims to determine if tACS can increase benefits obtained from an auditory
training program over the short and long term (Aim 2). Ultimately this work could significantly improve the
communication abilities of listeners with and without hearing loss who struggle with understanding in SOS
environments. This project coincides with NIDCD’s strategic plan of encouraging the development of new
technology to improve treatment.

Public health relevance
Project Narrative Many older adults with and without hearing loss struggle with understanding speech in the presence of other talkers. Noninvasive brain stimulation has shown promise for improving intelligibility in noise, but benefits in older adults who struggle most, and additional benefits beyond those obtained from behavioral auditory training have not been evaluated. This work tests a method of noninvasive brain stimulation in older adults struggling with speech mixtures to determine if it can increase benefits from auditory training.